Enrichment Core

ENRICHMENT PROGRAM: PROJECT SUMMARY
Scholarly activities and related research tend be pursued within narrow borders, constrained by disciplinary
lenses as well as program emphases. The Center for American Indian and Alaska Native Diabetes Translation
Research (CAIANDTR) promotes the interdisciplinary exchange of knowledge, skills, and experience that
promises to advance excellence in diabetes-related translational research relevant to American Indian and
Alaska Native (AI/AN) health. During this period of renewed support, the CAIANDTR will continue to: 1)
Contribute to relevant, standing UC/AMC seminars, symposia, and lecture series, and broaden the
presentations on diabetes translation research among AI/AN communities by including participation of SDPI
program staff collaborating with CAIANDTR investigators; 2) Augment technical assistance and training
webinars for Special Diabetes Program for Indians grantees to include focused presentations by CAIANDTR
investigators and Research Base members on diabetes translation research of particular interest to Native
communities, and 3) Document the increased reach, multiplicity, reciprocity, and density of social network
connections subsequently achieved through these enrichment activities. Capitalizing on the unique
opportunities afforded by close collaboration with the Special Diabetes Program for Indians, we will expand
these enrichment activities to active, program-driven settings that will promote more meaningful exchanges
among patients, providers, administrators, and scientists. Research Base members at 7 Satellite Centers
increase our reach to colleagues at other institutions sharing these aspirations.